DIDEOXYCYTIDINE FOR HIV POSITIVE PATIENTS ON PRIOR ZIDOVUDINE THERAPY

The purpose of this study is to evaluate the safety of ddC alone in combination with zidovudine versus zidovudine alone when administered to asymptomatic patients with a CD4 count <200 cells/mm3 and symptomatic patients with a CD4 count <300 cells/mm3 (ACTG 155)